Technology Train Dis

Project Summary Technology Training and Dissemination Core
The training of physical and computational scientists, engineers, as well as researchers from
other relevant disciplines, regarding clinical and process issues related to the development of
point-of-care devices is critical to accelerating the translation of these technologies into clinical
use. Identifying and understanding the needs of clinical end users and the sites at which
devices will be used is fundamental to a successful device design process. Development of
acceptable, affordable point of care tests (POCTs) for sexually transmitted infections (STIs) is a
public and population health imperative at this time of increasing national and global incidence
and decreasing treatment options. As part of the proposed Center of Excellence for the
Development and Testing of Point-of-Care Tests (POCT) for Sexually Transmitted
Diseases (STDs), we will: collaborate with all cores and continue to assess and communicate
unmet clinical and end-user needs for STI POCT development and adoption; identify potential
obstacles to moving along the developmental pipeline from other stakeholder perspectives
(policy makers, investors, marketers, lower and middle income country health systems); work
with national and international training partners to disseminate this information; provide a menu
of training opportunities to developers and other stakeholders including open-access web-based
trainings, in-person didactic and experiential sessions, observational preceptorships tailored to
developer needs, national and international conference presentation, and publications.